Nanoscale drug carriers for the treatment of Acute Respiratory Distress Syndrome (ARDS).

Proposal Summary/Abstract
Acute respiratory distress syndrome (ARDS) is an acute inflammation of the lungs. It represents 10% of all
intensive care unit (ICU) admissions in the United States. Despite decades of research and numerous large
clinical trials, there are few treatments for ARDS. This lack of disease-specific therapies is primarily due to
three main factors: First, ARDS patients are “fragile” due to frequent multi-system organ failure, and thus
cannot tolerate drug side effects. Second, ARDS, is very heterogeneous in its underlying pathophysiology, and
thus targeting a single pathway may not be sufficient. Third, the disease has a rapidly developing time course,
meaning that it can activate pathways that actively change patient outcomes in the order of hours.To solve the
above problems, the goal of this proposal is to develop and establish mRNA-loaded nanoparticles (mRNA-
LNPs) that can be targeted to specific cell types and organs, whereupon they can express multiple therapeutic
proteins as a platform technology for ARDS. Our lab has previously utilized three targeting moieties we use to
deliver nanocarriers: monoclonal antibodies binding to PECAM (an endothelial cell surface protein), ICAM
(another surface protein abundant on endothelial cells), and non-immune IgG (hereafter called “IgG”). We have
further shown that nanocarriers covalently coated with anti-PECAM and -ICAM antibodies are directed to the
lungs at levels 300-fold higher than “free drugs” (no carrier) addressing (problem #1), Further, mRNA-loaded
nanoparticles can be loaded with mRNA that encodes for various proteins, targeting various pathways
(problem #2). Additionally, mRNA-LNPs can express a variety of proteins for the length of time (~48 hours)
associated with the high-risk period of acute critical illnesses (problem #3) above. It seemed that we developed
a method to exclusively deliver therapeutics to the lung endothelium, as the standing theory was (without direct
evidence) that lung uptake was due entirely to endothelial cells. However, in pilot experiments, my sponsor and
I became aware that other cells reside in the pulmonary capillaries, marginated neutrophils. We found that
while PECAM coated particles are primarily taken up by the endothelial cells, we interestingly, in a paradigm
shift for the field of targted delivery to the lungs, found anti-ICAM targeted nanocarriers were taken up equally
by endothelial cells and leukocytes. This leads to the two key objectives of this proposal: 1) we want to
understand if with increases in leukocytes during ARDS, there will be a change in the cells that take up and
express anti-CAM targeted mRNA-LNPs and 2) develop a novel class of therapeutics for ARDS. This will be
done via 2 Specific Aims. Aim 1 will investigate the cell types that take up and express mRNA-LNPs both in
human, with ex vivo human lungs, and mouse models of ARDS. Aim 2 will investigate the therapeutic potential
of mRNA-LNPs by leveraging the Ang-Tie pathway to express Angiopoietin-1 to decrease pulmonary capillary
leak and finally testing expression capacity in mouse model as well as with ex vivo human lung. The result of
this project will inform future therapeutic design and develop a new class of therapeutic for ARDS, mRNA-LNP.

Public health relevance
Project Narrative Acute respiratory distress syndrome (ARDS) carries a 40% mortality rate. Despite high mortality rate, very little improvement has been made in treating this disease. The goal of this project is to develop nucleic acid loaded solid lipid nanoparticles for ARDS and to understand the types of cells that take them up in the context of ARDS, with the ultimate goal of therapeutic development.